NV 15495--PEG INTERFERON 2A VS ROBERON A IN PATIENTS W/ CHRONIC HEPATITIS

The objective of this study is to evaluate the safety and efficacy of 90 and 180 ug of PEG-IFN administered weekly compared to Roberon-A 3mu administered twice over a 48 week treatment period followed by a 24 week followup for patients with chc complicated by liver cirrhosis or transition to cirrohosis.